Project 2

Project Abstract: U19 Project 2
Cell-free DNA and Protein Wet-lab and Analyses in Pig to human Xenotransplantation
Xenotransplantation (XTx) of solid organs from domesticated pigs serves promising in mitigating the critical
organ shortages, with only ~25% of the waitlisted individuals receiving an allograft. Although recent
advancements including GGTA1 pig knockouts and FDA-approved GalSafeTM pigs have demonstrated efficacy
in overcoming hyperacute antibody-mediated rejection and extended survival in non-human primates, robust
and reliable biomarkers for monitoring xenograft cellular health and rejection are essential to progress to clinical
trials and usage in living humans. Current minimally invasive human allograft surveillance tests rely primarily on
donor-derived cell-free DNA (dd-cfDNA) which detects increases in cell-free DNA from damaged donor allograft
cells in the recipient plasma. However, methylated-dd-cfDNA (m-dd-cfDNA) offers increased specificity as
distinct methylation patterns make it feasible to distinguish cell-type-specific DNA from the xenograft. This may
be important in the context of defining the specific injury to a xenograft as early waves of antibody-mediated
rejection (AbMR) damage specific cell-types such as endothelial cells.
Using a combination of cfDNA and m-dd-cfDNA plasma patterns from pig-to-human decedent XTx studies and
pig kidney, liver, and heart xenograft atlases of major cell types using single-nucleus methylation whole-genome
sequencing (m-snWGS), our study aims is to develop prognostic and diagnostic markers of pig xenograft
damage, including AbMR and acute cellular rejection (ACR). Preliminary data from a 61-day pig kidney
xenotransplant study performed in NYU revealed a ~6-fold increase in pig kidney cfDNA during AbMR.
In the 61-day study, the end-of-study pig kidney xenograft biopsy was used to generate a cell atlas from 18,400
single nuclei. The nuclei were subjected to m-snWGS, revealing clear methylation differences for 14 major pig
kidney cell types. Methylated-dd-cfDNA data was generated in 13 timepoints across the 61-d study, and the
methylated patterns were mapped back to the pig kidney cell atlas. As there was a biopsy proven rejection event
in the middle of the 61-day study (as evident from conventional histological damage and in situ transcriptomics),
we selected several timepoints around this key event. Elevation of endothelial cell m-cf-ddDNA markers prior to
xenograft cellular damage were found. We specifically aim to perform nanopore sequencing of human recipients
of pig xenografts. Further, in pig xenografts, we propose to generate methylated single-nucleus whole-genome
sequencing atlases followed by their comparison with m-dd-cfDNA plasma of the recipients. We will also analyze
cell-free pig protein patterns from blood and compare them with cfDNA from equivalent timepoints. These efforts
will ultimately improve the xenograft survival and function by identifying specific cfDNA and protein diagnostic
and prognostic signatures in the plasma indicative of specific cellular damage in the xenograft.